ADV RES FOR RURAL COMM. AND MIGRANT HLTH CTR OPERATIONS

The purpose of this conference shall be to advance the current status of research concerning the operation of community and migrant health centers (C/MHCs) and their role in delivery of health care to underserved populations. A special emphasis will be to develop research designs that include understanding the contributions of C/MHCs in rural areas. The conference will have the following specific objectives: 1. To explore issues of policy concern vis a vis C/MHCs that are amenable to answers derived from health services research. These may include: measuring outcomes (clinical and program), understanding the impacts of welfare reform, and developing a role for C/MHCs in managed care. 2. To foster collaboration between those involved in operating C/MHCs and health services researchers interested in the delivery of services to underserved populations. 3. To analyze the contribution of published research to the understanding of how C/MHCs operate and the role they have in delivering service, including the special efforts C/MHCs make to provide services to otherwise underserved populations. 4. To explore methodological issues inherent in the study of C/MHCs. 5. To conclude with a research agenda related to C/MHCs and disseminate that agenda to community health centers and the health services research community.